ANALYSIS FOR NSC 726188 (3 LOTS): APPEARANCE, PROTON NMR, INFRARED, HPLC* (ASSAY, IMPURITY), MOISTURE (KF). POP IS 05/01/2020 - 09/30/2020

The purpose of the task is to perform QC analysis of new lots of bulk drug, in compliance with FDA regulations.